Imaging Core

Core C: Abstract
The overarching theme of program is to dissect a new concept that in Acute Respiratory
Distress Syndrome (ARDS), immunosuppression is a signature manifestation secondary to
unique, combinatorial pathways that modulate epithelial and myeloid cell viability and innate
immune function. We focus on pneumonia as a conceptual framework to study
immunosuppression, as pneumonia is a common cause and risk factor for ARDS. The faculty
within the Imaging Core have been collaborating continuously and productively with the PI’s of
this program for 23 years in various aspects of immunobiology, lipid biology
andairway/pulmonary biology resulting in 37 collaborative papers.
The principal roles of the imaging core will be; careful analysis of cellular and molecular
processes associated with apoptosis, necrosis, ferroptosis and other cell death mechanisms as
needed, characterization and quantification of cell types within tissues, examination of protein
expression during cell death, examination of cell-cell interactions in vitro, quantitative analysis
of cellular migration in vivo and ex vivo individual cells within tissues, and quantitative
measurement of the levels and patterns of expression of chemokines and cell-type markers
various samples at all levels of resolution. These studies will employ the full array of current
light, and potentially, electron microscopic methods including: single and multicolor
fluorescence microscopy, laser confocal microscopy live cell imaging, transmission electron
microscopy and computer-aided morphometric analyses . The Center for Biologic Imaging, in
which this core service will be performed, is designed for the purpose of providing state of the
art microscopic technologies to its users. It is equipped to perform a continuum of optical
methods including all types of light and electron microscopy essential to this Program Project.

Public health relevance
The Imaging Core (Core C) will analyze quantitatively biological processes such cell death, protein trafficking, and cell behavior at the cellular and subcellular level in a variety of cells and tissues using state-of-art imaging techniques to all investigators in the PPG application.